Development of a Low-Profile Dual Hormone Patch Pump with Novel Occlusion Sensor

Development of a Low-Profile Dual Hormone Patch Pump with Novel Occlusion Sensor Project Summary: The Specific Aim of this project is to develop a discrete, low-profile, dual hormone drug delivery system using SFC Fluidics’ enabling microfluidic technologies. A DualPump™ will be developed in which one proprietary ePump® body will independently and accurately deliver both insulin and glucagon from two separate reservoirs. Latching safety valve sets will independently and safely control the delivery of each hormone and a dispense confirmation sensor will notify the user of any dosing errors resulting from occlusions or electrical/mechanical failures. Phase II will see the integration of all components into an accurate, discrete, low-profile wearable pod, extensive benchtop testing and initial testing in swine. The end goal of Phase II is production of a DualPump module that has been introduced to the FDA and is ready to be integrated with all other components required for a dual hormone artificial pancreas. During Phase IIB, SFC Fluidics will work with manufacturers of continuous glucose monitors, control algorithms and stable drug formulations to develop an FDA-approved, robust, and reliable dual hormone artificial pancreas.

Public health relevance
Project Narrative: The proposed DualPump-APTM system will improve glycemic control as compared to an insulin-only Artificial Pancreas by providing the ability to correct a hypoglycemic condition. The DualPump-AP will have the necessary safety features and low dose precision to meet the need for insulin and glucagon delivery for people with Type 1 diabetes, especially children, adolescents, and individuals that are hypoglycemic unaware.